DOUBLE-B, PLACEBO-C, STUDY OF THE EFFECTS OF PREDNISONE ON SKELETAL MUSCLE

The purpose of this study is to examine the effect of troglitazone to reduce androgen levels and improve the central manifestations of polycystic ovarian syndrome (PCOS): anovulation, menstrual irregularity and hirsutism.